Development of 18F PET radiotracers for M2 microglia as diagnostics for multiplesclerosis pathogenesis

Project summary
Multiple sclerosis (MS) is the most common disabling neurodegenerative condition that affects young adults
around the world. Despite enormous efforts for treatment discovery, progressive disability, accompanied by very
significant adverse personal, medical and economic costs, remains very common. An important reason that
contributes to the unenviable track record of clinical trial failure for progressive MS is our inability to monitor in a
precise manner the status of MS at any given time. Although it has been established that the inflammatory cells
within the brain, known as microglia, are active in the progressive phase of the disease and most likely dictate
outcome, we remain unable to differentiate between MS-mediator and reparative microglia. Therefore, there is
a dire need to develop techniques that identify the subsets of microglia in order to stratify patients and offer them
adequate treatment.
Positron emission tomography (PET) has recently gained huge success as a non-invasive imaging approach to
accurately quantify biological processes within the brain. Thus far, PET imaging in MS patients has been
restricted to imaging a radioactive molecule, i.e. radioligand, that binds to a protein known as TSPO. However,
the recently observed variation of the TSPO gene, with some patients lacking binding of the radioligands, and
its inability to distinguish the activity of microglia limits its utility as a clinical and research tool. Building on our
previous results showing the selective upregulated expression of a protein by reparative microglia, we will
develop radioligands that bind to this protein and can be used for diagnostic purposes via PET. This highly
translational research plan will enable clinicians to classify MS in novel ways to guide therapeutic intervention in
MS patients in ways not previously possible.
The specific aims of this project are to (i) design and synthesize next-generation radioligands with optimized
binding and CNS penetration; (ii) generate radioactive versions of leading compounds; (iii) validate the
radioligands in MS mouse brain slices and assess them by PET in MS mouse models.
Outcome: This work will result in a diagnostic reagent that, using imaging equipment, will help clinicians monitor
the status of progressive MS in patients being treated in a manner that has never been possible before and
improve the success rates of new MS drugs being tested in clinical trials.

Public health relevance
Project narrative Microglial activation is increasingly recognized as an important component of the nervous system’s response to demyelinative injury in progressive multiple sclerosis (MS); however, our current inability to identify the nature and extent of the microglial response to injury limits our monitoring of the therapeutic response. Our proposed studies aim to fill this gap by developing a PET radioligand as a diagnostic tool that can differentiate the subsets of microglia in order to stratify MS patients. This stratification will allow a more accurate prediction of disease outcome and monitoring of therapeutic response, as well as the development of novel treatment strategies.